Manufactured Food Regulatory Program Standards

Indiana State Department of Health Conformance with the MFRPS PI: Scott Gilliam RFA-FD-12-007 Project Summary/Abstract: This funding opportunity will allow Indiana to contribute to a nationally integrated food safety system by striving to achieve and maintain full conformance with the manufactured foods regulatory program standards (MFRPS). The MFRPS would be used to assist Indiana in developing and maintaining best practices for a high-quality regulatory program. The MFRPS will benefit consumers by the development of CodePal, an interactive food database system, and by ensuring the Indiana State Department of Health (ISDH) Food Protection Program (FPP) is consistent with stringent national standards. The ISDH FPP will contribute to the upcoming 2013 Public Health Accreditation Application to ensure the Center for Disease Control and Prevention's 10 Essential Services are being met by the agency. Conformance with these program standards will align with the ISDH mission to promote and provide essential public health services to protect Indiana communities and is considered as equivalent to this accreditation by the Public Health Accreditation Board. It will also help Indiana contribute to Federal and other State programs to better direct their regulatory activities at reducing foodborne illness hazards in plants that manufacture, process, pack, or hold foods. 1

Public health relevance
Project Narrative: ISDH completed its 5-year assessment in July for 2011-2016, the Indiana State Health Improvement Plan (I-SHIP), which incorporated in to "Assure Food Safety" as a top priority. This can be accomplished through education and working towards compliance with the Food and Drug Administration (FDA) MFRPS. This funding would allow the ISDH FFP to have a direct influence on public health in the nation and significantly impact the health of Hoosiers. 1 __SpecificAimsTextDelimiter__ Indiana State Department of Health Conformance with the MFRPS PI: Scott Gilliam RFA-FD-12-007 Specific Aims Goal - The Indiana State Department of Health (ISDH), Food Protection Program (FFP) will contribute to a nationally integrated food safety system by achieving and then maintaining full conformance with the manufactured food regulatory program standards (MFRPS) by September 11, 2017 which will provide the ISDH FPP a direct influence on public health in the nation and significantly impact the health of Hoosiers by reducing foodborne illness. Outcomes - ISDH FPP conformance with the MFRPS will dramatically improve process outcomes such as, implementation of critical positions, systems, and providing proper equipment ultimately enabling the ISDH FPP to a highly functioning public health program. Conformance with the MFRPS will improve public health by preventing foodborne disease and injury by either intentional or unintentional means. It is anticipated that conforming with the MFRPS will directly correlate to the decrease in negative food safety occurrences. Objectives - " A MFRPS Project Coordinator will facilitate conformance with the MFRPS by using the completed baseline self assessment, new policies and standard operating procedures are to be developed and implemented, with assistance from FPP staff, to address any and all gaps in conformance with the MFRPS. This position is also responsible for maintaining the grant and contract timelines and deliverables. " Finish and roll out the FPP electronic data collection and inspection program called CodePal, so that the local health departments, food industry and the public can begin using the system and drastically improve the data of food establishments, including demographic, complaints, outbreak reports, samples, licensure/registration and inspection data. " Provide smart phone technology to the FPP staff to improve communication capacity for outbreak response, compliance and enforcement and reduced time lag in response to our constituents. " Obtain essential equipment, such as inspection tools and updated computers through the State equipment "refresh" program. " Develop a Training and Auditing Coordinator position that is responsible for insuring the training needs and requirements for the FPP staff are complete, accounted for and kept current. This position is also responsible for conducting audit inspections of the FPP staff and to assist with any program assessment validation audits (PAVA) with FDA. " Develop a Rapid Response Team Coordinator position that will work closely with the ISDH Epidemiology Resource Center (ERC) to investigate outbreaks of foodborne disease and other emergencies directing environmental health assessments and food/environmental sampling related to these situations. The position will be housed in the ERC to facilitate rapid response. " Completion of the ISDH Public Health Accreditation through the Public Health Accreditation Board. " Completion of the Indiana State Health Improvement Plan, Assure Food Safety Priority, strategies and outcomes that correspond with accreditation and the MFRPS. 1